Non Magnetic MRI Conditional External Defibrillator with Reduced Skeletal Muscle Contraction

Delays in defibrillation reduce survival from cardiac arrests due to ventricular fibrillation (VF). Delays in
defibrillation of MRI patients occur due to the need for removal of the patient from the scanner, placement onto
an MRI safe stretcher, and relocation to a nearby environment containing a defibrillator. Current defibrillators
cannot be near the scanner since the MRI magnet can draw the defibrillator into the scanner, which can cause
serious injuries or death. Defibrillation can be further delayed since defibrillation of MRI patients is typically
performed by code teams that respond from other, often distant, locations, rather than MRI staff. Each minute in
delay to defibrillation can reduce survival by 10-12%. The unmet clinical need, therefore, is the lack of availability
of a system that would allow defibrillation next to or in the MRI scanner, thereby minimizing delays. The
consequences of adverse outcomes from cardiac arrest in MRI scanners are catastrophic, requiring
reducing risks as much as possible, by the availability of immediate MRI safe defibrillation. These delays
are especially problematic since cardiac arrest from VF can complicate anesthesia administration, which is used
in many of the over 45 million MRI scans done yearly in the United States. Even with modern methods, cardiac
arrest can still occur during anesthesia management, with mortality as high as 30%. In addition to anesthesia-
based procedures, there are a number of MRI-guided interventions with an increased risk of VF. There are also
MRI-guided interventions not currently being performed, such as ablation of ventricular tachycardia, because of
the high risk of VF, and the lack of the availability of immediate defibrillation. Cardiac arrest can also occur during
routine MRI scans without anesthesia. The central hypothesis is that a defibrillator can be developed that would
allow defibrillation in the MRI scanner, reducing delays, and allowing procedures with a higher arrhythmia risk to
be done under MRI guidance. Defibrillation can be done in the scanner because of the MRI compatible properties
of the system, and because motion of the patient caused by the shock is substantially reduced by a pre-shock,
ramped High Frequency Alternating Current (rHFAC) waveform that reduces substantially the shock-induced
skeletal muscle contraction, avoiding the patient “jumping” into the scanner bore walls. The overall objective of
this proposal is to develop a clinical grade, MRI conditional defibrillator with the rHFAC waveform for submission
to FDA for 510(k) clearance, which FDA has already indicated is acceptable. The Phase I objectives have been
achieved. In addition, Coram has negotiated an exclusive license from Johns Hopkins University for an MRI
conditional defibrillator with the rHFAC waveform, and has filed a patent on using non-magnetic transformers to
improve performance. The Specific Aims are: 1) To develop a clinical grade, MRI conditional external defibrillator
with the rHFAC waveform; 2) To perform verification and validation testing; and 3) To determine the optimal
workflow for defibrillation in the MRI scanner. If successful, this system could become a “must have” for any MRI
scanner with monitoring equipment, which represents half of the over 14,000 MRI scanners in the United States.
** This section contains proprietary information

Public health relevance
This project is for commercialization of an advanced defibrillator system that can be used in or near an MRI scanner, allowing much faster defibrillation of patients undergoing MRI scans, and needing rapid defibrillation. Currently, delays in defibrillation are caused by the requirement to move patients from the MRI scanner room to defibrillate, which can reduce the chances of survival from ventricular fibrillation. The system also reduces substantially the amount of skeletal muscle contraction that would otherwise be caused by the defibrillator shock, resulting in much less patient motion caused by defibrillation, and allowing defibrillation with the patient in the MRI scanner bore.